The Role of Oogenesis in Speciation

Project Summary
All biodiversity on earth is generated through the process of speciation. While speciation research is focused
on the origins of reproductive barriers between species, the results of this work will inform the study of
infertility, an important reproductive health concern. Though gametogenesis is a logical developmental process
to study in regard to reproductive isolation, nearly all research focuses on male gametogenesis, with little to no
work on oogenesis. The proposed research hypothesizes that environmental stress hastens the accumulation
of genetic divergence through its impact on oogenesis, drawing connections between reproductive and
environmental health. For example, environmental stress has been shown to cause recurrent spontaneous
abortion, making this work relevant to public health. There are four key outcomes of environmental stress on
oogenesis – transposable elements, structural variants, meiotic recombination rates, and gene regulation –
that have been shown to be important to the study of speciation. By increasing genetic differences, oogenesis
facilitates speciation between species that are differentially exposed. This proposal focuses primarily on
recombination, while taking an important step towards integrating other outcomes. Previous research has
shown that recombination rates evolve more rapidly than nucleotide divergence. This coupled with evidence
that recombination rates are environmentally sensitive, suggests that the environment could be a major driver
of local adaptation through recombination. This proposal leverages the ease of experimental manipulation in
fruit flies to study the link between environmental sensitivity of oogenesis, the accumulation of novel genetic
variation, and subsequent species divergence. First, within species oogenesis will be compared to hybrids
under control and stress conditions investigating gene expression, chromatin conformation, organismal
measures of stress response, and recombination. By targeting molecular pathways associated with
transposable element silencing and DNA repair, this work can indirectly inform the accumulation of these novel
genetic variants, answering a key question in evolutionary biology regarding sources of intra- and inter-
species variation. Second, because differences in hybrid oogenesis could be attributed to reproductive
incompatibilities impacting fitness, this work will investigate the relationship between fitness and recombination
plasticity directly with three unique experimental stress treatments. Mutant markers will be used to compare
recombination, with the aid of a novel high-throughput phenotyping robot. Wild type stocks known to be either
sensitive or tolerant to selected stressors will be targeted. A major innovation of this work will be to investigate
organismal stress response directly to compare fitness across treatments. The data collected from these two
questions will be critical in the broader investigation of mechanisms of recombination rate plasticity, which
remains a mystery even after a century of research in this area. In five years, the proposed work will answer
crucial questions in speciation, while also filling a major gap of the importance of oogenesis in speciation.

Public health relevance
Project Narrative Environmental health is an important component of public health programs, with developmental processes such as reproduction, particularly vulnerable. Through its impact on reproductive health, the environment generates novel genetic variation that can lead to reproductive incompatibilities, which can ultimately cause infertility between individuals that have been differentially exposed. This proposal will study how the environment impacts oogenesis to produce genetic incompatibilities.